Administrative Core

Core C Administrative The purpose of this Program is to bring together a team of investigators to focus on the pathobiology of two important disease states, chronic allergic asthma and idiopathic pulmonary fibrosis using both state-of-the-art animal modeling and human samples. The goals of this Program are to improve our understanding of the mechanisms that contribute to disease progression and identify novel therapeutic targets to combat lung fibrosis whether it occurs in the airway or in the interstifium of the lung. The Program brings together a team of scienfists and physician scientists with complementary skills to work as a unit on these important problems. In order to coordinate these efforts we propose an Administrative Core to facilitate interactions and adherence to NIH regulations regarding management of P01 proposals. We propose the following Specific Aims: Coordinate and facilitate administration of the Program between Project Leaders and Core Leaders. Coordinate and facilitate administration of the Program between investigators, internal and external advisors and an enrichment program organized to maximize scientific productivity.

Public health relevance
RELEVANCE There are no effective therapeutic approaches to limit airway remodeling and interstitial fibrosis. Our proposal brings together experts in surfactant biology, interstitial fibrosis and translational asthma research and will provide mechanistic insights into how endogenous host factors regulate chronic inflammation, airway remodeling and interstitial fibrosis in mouse and man with the potential to provide new therapies for these severe diseases.